ROLE OF MODERATE DAILY WINE CONSUMPTION UPON INSULIN SENSITIVITY

The intent of this study will be to demonstrate the effects of regular moderate wine consumption upon insulin mediated glucose uptake over a ten week interval. Our hypothesis is that wine, added to normal daily food intake, will improve insulin sensitivity in middle aged women.